Evolution and inhibition of beta-lactamase activity in antibiotic resistance

DESCRIPTION (provided by applicant): The production of serine β-lactamase is one of the primary resistance mechanisms used by Gram-negative bacterial pathogens against β-lactam antibiotics, which include the widely used penicillins and cephalosporins, as well as last resort antibiotics such as the carbapenems. The development of novel β-lactamase inhibitors is a pressing need underscored by the continuing mutation of β-lactamases. We propose the development of high affinity non-covalent β-lactamase inhibitors by targeting conserved structural motifs, particularly those essential for extended spectrum β-lactamase activity. Prototypes of these inhibitors have already been identified. Specifically, using the CTX-M Class A β-lactamases as a model system, we aim to: 1) apply a fragment-based and structure-guided approach to develop novel β-lactamase inhibitor chemotypes; 2) study resistance and ligand binding by ultrahigh-resolution and room-temperature X-ray crystallography; and 3) investigate the evolution of resistance mutations against non-covalent inhibitors. These experiments will lead to new β- lactamase inhibitors with clinical potential, while providing a deeper understanding of β-lactamase mutations relevant to resistance evolution.

Public health relevance
CTX-M Class A β -lactamase, one of the most common extended spectrum β-lactamases in Gram-negative bacteria, confers bacterial resistance to a broad range of β-lactam antibiotics and is the cause of great health concern. The studies outlined in this proposal aim to develop a new class of inhibitors against CTX-M and other serine β-lactamases as well as to understand the catalytic mechanism of these enzymes. The results will contribute to the efforts of novel antibiotic development.